1/2 Howard - Hopkins Comprehensive Alliance in Cancer Research, Education, and Equity (H2CAREE)

PROJECT SUMMARY
In response to NIH PAR-23-308, the Howard-Johns Hopkins Comprehensive Alliance in Cancer Research,
Education and Equity (H2CAREE) initiative aims to advance cancer care and health equity through the
partnership between Howard University (HU) and the Johns Hopkins University (JHU) Sidney Kimmel
Comprehensive Cancer Center (SKCCC).
Situated in the vibrant DC, Maryland, and Virginia (DMV) area, the two institutions collectively have a direct
impact on a population of 4 million historically underserved African Americans in the area, with over 2 million
Black residents in the metropolitan of Washington DC and Baltimore. Focused on DMV region, the initiative
strives to address healthcare disparities in this diverse and significant demographic. Howard University and
Johns Hopkins University possess distinctive strengths that complement each other in achieving the proposed
goal through integrated research, research education, and outreach. The primary objectives are to establish
and sustain collaborative cancer research programs with an emphasis on health equity, to boost cancer
research education programs at HU, and to advance cancer care for traditionally underserved
populations through outreach activities.
The H2CAREE initiative comprises of four Cores (Administrative, Outreach, Research Education, and Planning
& Evaluation); two Full Research Projects; one Pilot Research Project; and one Shared Resource Core (Data
Science). With these assets and activities, the Partnership will: 1) through research projects, the shared resource
core, and the research education core, increase cancer research and research education capacity at HU; 2)
through the research projects, improve research programs focusing on cancer health disparity at SKCCC; 3)
through the research project and the research education core, increase the number of investigators and students
conducting cancer health disparities research; 4) through the research education core and outreach core,
promote the diversity of the cancer research workforce by increasing the number of African American students
pursuing cancer research; and 5) through the outreach core, develop and implement cancer outreach and
education initiatives that benefit both locally, i.e. the DMV region, and nationally. Additionally, the Planning and
Evaluation Core will continually assess/evaluate outcomes of the cores, research projects, and shared
resources. Together, the collection of the efforts in H2CAREE will contribute to elimination of cancer health
disparities.

Public health relevance
PROJECT NARRATIVE Building on the longstanding collaboration between Howard University (HU) and Johns Hopkins University (JHU), especially the Howard University Cancer Center (HUCC) and the JHU Sidney Kimmel Comprehensive Cancer Center (SKCCC), this application is to reignite the U54 CPACHE between the two institutions. The Howard-Johns Hopkins Comprehensive Alliance in cancer Research, Education, and Equity (H2CAREE) initiative is committed to the elimination of cancer health disparities in racial/ethnic minority and underserved populations in the DC, Maryland, and Virginia (DMV) region, particularly among African Americans. By leveraging the distinct yet complementary strengths and resources of the two institutions, we proposed rigorous and collaborative transdisciplinary research, research education, and outreach programs that will improve cancer care and health equity.